Diabetes Research Center

The Diabetes Research Center at the University of Washington has existed for over four decades and is part of
the national program supported by NIDDK. It acts as the focal point and umbrella for diabetes research in the
Greater Seattle area with the goal of promoting an environment of collaborative research on diabetes, obesity
and related disorders by (1) Providing support to affiliate investigators through its biomedical research cores;
(2) Conducting a pilot and feasibility program that provides grant support for new investigators in diabetes
research and to established investigators in other disciplines; (3) Sponsoring an interactive enrichment
program comprising lectures, retreats and symposia to inform the community of the latest developments in the
area; (4) Ensuring the development of young investigators by providing postdoctoral and graduate student
fellowships for salary support and training in its biomedical research cores; and (5) Developing new research
methods and technologies based on the evolving needs of its investigators. To accomplish this goal, the
Center is organized around five biomedical research cores (Cell Function Analysis Core, Cellular and
Molecular Imaging Core, Human Studies Core, Quantitative and Functional Proteomics Core, and Vector and
Transgenic Mouse Core) and an Administrative Core that also manages the Pilot and Feasibility Program and
the Enrichment Program. Along with the commitment of the University of Washington and other Seattle
institutions of research space and additional financial support, the Diabetes Research Center is a dynamic and
constantly evolving center that supports 99 Seattle-based affiliate investigators who are making important
scientific contributions in the areas of (1) Pathophysiology, prevention and treatment of type 2 diabetes; (2)
Central regulation of body weight and glucose metabolism; (3) Complications of diabetes; (4) Etiology,
pathogenesis and treatment of type 1 diabetes; and (5) Clinical trials and large-scale epidemiologic studies.

Public health relevance
PROJECT NARRATIVE The Diabetes Research Center at the University of Washington has a long-standing tradition and record of facilitating scientific investigation aimed at informing on how best to treat and prevent diabetes. Through its biomedical research cores, Pilot and Feasibility Program as well as its Enrichment Program, it will continue to support over 100 scientists in the Greater Seattle area and beyond who are pursuing basic, translation and clinical investigation in diabetes and related disorders.